TRICYCLIC ANTIDEPRESSANTS AND OPIOIDS IN MANAGEMENT OF POSTHERPETIC NEURALGIA

Determine the effectiveness of two medications, tricyclic antidepressants (TCA) and opioids, compared to a placebo in the treatment of post-herpetic neuralgia.